Biomedical Raman Imaging Workshop

Summary The purpose of the planned conference is to facilitate development of Raman-spectroscopy based clinical appli- cations. Raman scattering provides label-free contrast for imaging that derives from intrinsic molecular vibrations. Because it is label-free and reports in an unbiased way on all molecular species in a sample, it provides a holistic “view” of the chemical environment in clinical samples, and thus holds signiﬁcant value as a diagnostic and treatment monitoring tool. While the phenomenon of Raman scattering has been known since 1920, and its clinical potential has been recognized for many decades, roadblocks including weak signal levels and complexity of its readout has precluded it from clinical use. These roadblocks are now being removed through innovations in instrument development and machine learning.

Public health relevance
Narrative Raman spectroscopy provides diagnostically important chemical proﬁles of clinical samples, withouth the need of labeling. Throgh this it holds tremendous potential to improve many diagnostic and monitoring aspects of healthcare. The purpose of this workshop is to facilitate efﬁcient development of these techniques in a way that will be clinically acceptable.